Regulation of cellular plasticity and regeneration in Drosophila spermatogenesis

Abstract
Many adult tissues replace cells lost due to normal wear and tear through the activity of stem
cells, but can use entirely different strategies when injury occurs. The ability to understand and
control regeneration, or the regrowth of lost tissues or organs in response to injury, is a long-
standing goal in biology. Cells with the capacity to adopt the biological properties of other cell
types under specific conditions, or cellular plasticity, are key contributors to regeneration. Stem
cells and even differentiated cells can have surprising degrees of plasticity, allowing them to
adopt new fates and rebuild damaged tissues. This happens in response to altered
microenvironments that arise upon injury, but the mechanisms that regulate plasticity are poorly
understood. We have developed the Drosophila testis as a model system to study the biology
of stem cells and their microenvironments, or niches. Advantages include the relative simplicity
of this tissue and an unparalleled collection of genetic tools to probe it functionally. Previously,
we showed that damaging the Drosophila testis converts differentiating germ cells to revert to
germline stem cells to repair the tissue. We recently found that quiescent somatic niche cells
can transdifferentiate into new somatic stem cells upon damage. Here we combine live
imaging, lineage tracing and single cell transcriptomic profiling to determine now niches sense
damage and then activate program(s) to regenerate missing stem cells. We will also uncover
the overall complexity of the genetic pathways enriched in the testis niche during normal tissue
turnover, following up on candidate signals that relay information from stem cells to their niche.
Our synergistic approach will enhance the understanding of the fundamental cellular and
molecular mechanisms driving homeostasis and regeneration in the testis, which has important
implications for understanding fertility, regeneration and cancer.

Public health relevance
NARRATIVE This work will contribute significantly to what is known about the mechanisms promoting regeneration in living adult animals. By using complimentary genetic and genome-wide approaches in the Drosophila testis, we will identify the cellular and molecular mechanisms that enable tissues to sense damage and then activate a program to regenerate missing stem cells. These mechanisms are of strong general interest, as they will suggest successful therapeutic strategies for achieving healthy tissue regeneration more generally.